Graduate and Undergraduate Researchers of UCEER (GURU)

PROJECT SUMMARY/ABSTRACT
The phrase “nothing about us without us” has guided disability rights advocates for decades. The basic premise
of the phrase is that conversations about disability, policy decisions affecting people with disabilities, and
technological developments impacting disabled people should include members of the disability community, so
that they can bring their lived experiences with disability to the table. “Nothing about us without us” is
particularly relevant to the domain of genetic science and genetic medicine because it informs a range of
disability-oriented criticisms aimed at those practices. For example, critics argue that prenatal genetic testing,
used in part to facilitate decisions about bearing children with disabilities, endorses the idea that disability is
something to be avoided rather than accommodated. Parents making decisions about the result of a genetic
test, disability advocates warn, are often given poor information about what it is like living with the disability in
question.
Attempts to involve people who identify as having disabilities in conversations about the ethical, legal, and
social implications (ELSI) of genetic technologies, policies, and practices are hindered by the fact that, while
students who identify as having disabilities are enrolling in higher education at increasing rates, those students
are also dropping out at higher rates. Long-term mentorship programs are one way to address this retention
problem; in particular, programs that embed students who identify as having disabilities into mentorship
networks with multiple mentors at the near-peer and faculty levels, and both with and without disabilities,
have proven effective. These programs foster social integration, self-determination, and a sense of purpose. The
goal of the University of Utah's Graduate and Undergraduate Researchers of UCEER (GURU) Program is to
continue equipping undergraduate (2/year) and graduate (2/year) students with disabilities with mentoring,
research, and curricular resources that facilitate their advancement towards becoming members of the ELSI
community. Mentoring resources include a mentor network that incorporates a local project faculty mentor, an
external member at a different institution who also identifies as having a disability, a near-peer mentor, and a
GURU mentor who monitors their overall progress. Research resources include the opportunity to participate
in one or more ELSI research projects, and then support to present the results of that research at a local
research symposium and at national academic conferences. And curricular resources include enrollment in an
interdisciplinary ELSI course, training in the responsible conduct of research, and a grant writing workshop.

Public health relevance
PROJECT NARRATIVE The Graduate and Undergraduate Researchers of UCEER (GURU) Program equips students who identify as having disabilities with mentoring, research, and curricular resources that facilitate their advancement towards becoming members of the ELSI community. Disability rights advocates argue conversations about disability, policy decisions affecting people with disabilities, and technological developments impacting disabled lives should include members of the disability community; however, this demand—“nothing about us without us”— has been hindered by the fact that individuals who identify as having disabilities are underrepresented in academia. The GURU Program embraces this demand by creating a pipeline for a future generation of ELSI scholars who have experience living with disability.